Quality Control of the cilia proteome

PROJECT SUMMARY
Primary cilia organize signaling pathways such as vision, olfaction and Hedgehog signaling and dysfunction
of cilia causes a host of symptoms in disease collectively known as ciliopathies. The movements of signaling
receptors into, inside and out of cilium are critical for the correct regulation of these pathways. Past work from
the lab identified two paths for the regulated exit of signaling receptors out of cilia. One route goes back into the
cell and has now been extensively characterized. Another route packages signaling receptors into extracellular
vesicles (EVs) and its mechanisms remain poorly understood.
The major goal of this proposal is to determine the molecular mechanisms for signaling receptor packaging
into ciliary EVs. A major goal of this proposal is the generate genetically encoded disrupters of ciliary EV
shedding. These tools will enable a rigorously test of the physiological importance of ectocytosis.

Public health relevance
PROJECT NARRATIVE Dysfunction of the primary cilium causes obesity, skeletal abnormalities, kidney cysts and retinal degeneration. The proposal aims to uncover the basic principles that underlie the packaging of ciliary signaling receptors into extracellular vesicles. If successful, this research program will further our understanding of retinal degeneration and obesity and provide novel means for therapeutic intervention.